The NKI Rockland Sample II: An Open Resource of Multimodal Brain, Physiology & Behavior Data from a Community Lifespan Sample

ABSTRACT. The present competing renewal application proposes to create the next generation NKI-Rockland
Sample (NKI-RS) initiative. The NKI-Rockland Sample (NKI-RS) has served as a beacon for lifespan
connectomics research, providing a model for accelerating the pace of psychiatric discovery science. More than
200 publications have used NKI-RS, generated largely by independent investigators and in major journals. Since
2011, it has generated and publicly shared (on a quarterly basis) a large-scale (N > 1400), deeply phenotyped,
community-ascertained, cross-sectional, lifespan sample (ages 6–85 years old) with advanced connectomics-
focused neuroimaging (i.e., diffusion MRI, resting state fMRI [R-fMRI]) and genetic samples. Recently launched
large- scale efforts, such as the HCP Lifespan Studies and the NIH ABCD Study are working to bring to scale
human connectome mapping and brain function across the lifespan, using ‘battle-tested’ imaging technologies
and strategies. These ongoing studies are less focused on mental health. Moreover, technologies and ideas
continue to evolve - often too rapidly to permit timely testing and inclusion in ongoing research. The overarching
goal of the present proposal is to create the next generation NKI-RS initiative that will once again extend the
vanguard in the study of lifespan connectomics by enriching and expanding the landscape for neuroscientific
advancement and biomarker discovery. Three major themes have guided the design of the proposed NKI-RS-II
lifespan resource: 1) multimodal measurement integration across functional domains (e.g., fMRI, EEG, mobile
brain/body imaging [MoBI] framework), 2) ecological sampling (e.g., wearables, sensors, smartphones apps),
and 3) enhanced physiological phenotyping for cardiovascular fitness and obesity. Specifically, in a community-
ascertained lifespan sample (N=600; ages 9-75; M: F = 1:1; age range selected to maximize data yield and
tolerability), the proposed work aims to: 1) Generate and share large-scale multimodal MRI/EEG imaging data
complemented by comprehensive phenotyping of cognition, behavior, and psychiatric status, from human and
sensor-based informants; 2) Optimize brain-age prediction across the lifespan using multimodal data (R-fMRI,
Naturalistic Viewing fMRI [NV-fMRI], dMRI, T2/T1, R-EEG, NV-EEG) and relate deviations from chronological
age to dimensions of psychopathology and cognitive performance; and 3) Identify the relationship of modifiable
health risk factors (e.g., fitness, obesity, physical activity, substance use) to deviations between predicted brain
age and chronological age across the lifespan. Consistent with the model established by the previously funded
NKI-RS initiatives, all data will be shared prospectively, on a quarterly basis, via the International Neuroimaging
Data-sharing Initiative (INDI) and the NIMH Data Archive (NDA).

Public health relevance
NARRATIVE. The openly-shared NKI-Rockland Sample has provided a model for lifespan imaging studies and has led to more than two hundred publications to date. This competing renewal application will provide a comprehensive data resource to enrich and expand resources available for brain research and biomarker discovery across the lifespan. Construction of the proposed sample was organized around three main themes: 1) integration of advanced measures for brain and body, 2) real-world strategies for characterizing individuals, and 3) enhanced focus on the relationships between obesity and cardiovascular fitness on brain function.